Post-Translational Control of TET Function in Lymphoma

TET DNA hydroxylases are alpha-ketoglutarate (αKG)-dependent enzymes that catalyze the oxidation of 5mC
to 5-hydroxymethylcytosine (5hmC), thus promoting DNA demethylation. Mapping of 5hmC marks at single base
resolution demonstrated that the main role of TET enzymes is to maintain gene enhancers hypomethylated and
active. Enhancers are genomic areas to which transcription factors bind to modulate gene expression programs.
Hyperactive clusters of enhancers that are densely occupied by transcriptional factors are termed super-
enhancers and are typically found in cancer. Like promoters, enhancers/super-enhancers are regulated by their
DNA methylation status, a process that often goes awry in cancer. Thus, given that active enhancers and super-
enhancers are oncogenic in nature, and that TET enzymes maintain them hypomethylated and active, we
postulate that increased TET activity may itself be oncogenic. Mitochondria function as signaling organelles by
generating substrates that fuel epigenetic changes, including for example acetylation and methylation of DNA
and histones, respectively. Recently, we and others described a subtler interplay between mitochondria and
epigenetics, wherein the levels of the intermediate metabolites αKG and 2-hydroxyglutarate were found to
modulate the activity of TET enzymes, thus controlling DNA methylation. These findings led us to hypothesize
that intermediary metabolism plays as an important role in the control of DNA methylation. Specifically, we
posited that the mitochondrial enzymes D-2- and L-2-hydroxyglutarate dehydrogenase (D2HGDH and
L2HGDH), which catalyze the interconversion of 2-HG to αKG, are integral to the cross talk between
mitochondrial metabolism, TET function and super-enhancer demethylation/activation. To expand on this initial
concept, we sought to identify upstream signals that regulate D2HGDH and L2HGDH expression and,
consequently, influence TET function and enhancer methylation/activity. Using reporter and ChIP assays,
inducible cell lines and mouse models, we recently reported that MYC transcriptionally activates D2HGDH and
L2HGDH and, in a D2HGDH/L2HGDH/αKG-dependent manner, induces TET function leading to DNA
demethylation in vitro and in vivo. Remarkably, we discovered that the MYC/D2-L2HGDH/αKG axis also
promotes the nuclear accumulation of TET1, TET2 and TET3, in association with enhanced O-GlcNAcylation, a
post-translational modification executed by another mitochondrial enzyme, O-GlcNAc transferase (OGT).
Further, we preliminarily showed that in in diffuse large B cell lymphoma (DLBCL), MYC levels associated with
enhancer methylation and target gene expression. Together, these data uncovered a novel mitochondrial
signaling axis which includes MYC at the proximal point, D2/L2HGDH and OGT at the center, and, distally, TET
activity and subcellular location. In this proposal, we will use human B cell lymphoma models in vitro and in vivo,
to test the overarching hypothesis that intermediary metabolism, in part due to MYC activity, induces TET
function, maintains oncogenic enhancers/super-enhancers hypomethylated and active and promote cancer. Our
specific aims are: AIM 1) Determine the mechanistic basis for the increased O-GlcNAcylation mediated by the
MYC-D2/L2HGDH-αKG axis and its role in promoting TET nuclear localization and enhancer activation. AIM 2)
Define the contribution of the TET activation to MYC-driven lymphomagenesis AIM 3) Characterize the MYC-
driven map of 5hmC marks and super-enhancer activation in B cell lymphoma. The proposed study is significant
because it will define, and mechanistically elucidate, a novel role for MYC in cancer, i.e., activation of oncogenic
enhancers/super-enhancers. Downstream to MYC, the contribution of D2HGDH-L2HGDH (via αKG generation)
and O-GlucNAcylation will impart a post-translational control of TET function, which challenges the current
dogma that these enzymes function exclusively as tumor suppressors.

Public health relevance
Lymphoma, a tumor of the blood cells, is the fifth most common cancer type in the western world. Importantly, lymphoma is one of the few cancers for which the risk was significantly increased among Vietnam veterans. In addition, more recent data (1996-2007) from Italian army peacekeeping troops in the Balkans, also preliminarily suggested an increase in lymphoma incidence. Although the mechanism associated with this elevated risk of lymphoma development have not been fully defined, chemical exposure in the battlefield as well as contact with infectious agents are likely possibilities. Thus, it should be expected that with the current extended deployment of US military forces in foreign lands, a new wave of increased lymphoma diagnosis in military personnel may ensue. To specially attend to the needs of this population, we critically need research that: a) leads to a better understanding of lymphoma biology, b) identifies novel biomarkers for diagnosis and early detection, and c) facilitates the development of more effective and less toxic therapeutics.